Administration

ADMINISTRATION: ABSTRACT
Mayo Clinic Comprehensive Cancer Center (MCCCC) Administration partners with the enterprise Executive Director of MCCCC (Cheryl L. Willman, MD), Senior Leaders (Site Directors, Enterprise Deputy Directors, CCSG Component Leaders), Research Program (RP) Leaders, Shared Resource (SR) Directors, Disease Group Leaders, Clinical Research Leaders and members to advance the Center’s mission through innovative and effective administrative operations, data analytics, and novel research infrastructure. MCCCC is a single integrated matrix cancer center across the three Mayo Clinic Destination Medical Center sites with 363 members from 41 departments with 116 recruited in the last 5 years. MCCCC members hold $74.2M in annual direct cancer-relevant, peer-reviewed funding including $45.9M from NCI. MCCCC Administration is agile, experienced, collaborative and excels in leveraging the rigorous administrative team across three broad geographic locations: MCCCC in Rochester (MCR), Arizona (MCA), and Florida (MCF). Administration is exceptional in data analytics and tools to advance informed decision making, advancing scientific collaboration, facilities and technology planning, managing RPs and scientific retreats across three sites, internal Pilot Project competitions, Cancer Clinical Trials operations, Cancer Research Training and Education (CRTEC), Community Outreach and Engagement (COE), and compliance with all Mayo Clinic policies and federal and state requirements and regulations. Administration facilitates all internal and external strategic planning and evaluation efforts, partners with the Mayo Clinic Research Shield to develop and implement research administration policies and has shared oversight of SRs. Administration is responsible for internal and external communications and marketing, including social media and a new website, clinical research, and staffs the MCCCC Executive Committee, Senior Leadership Committee and other governance committees. Administration supports the Executive Director and Senior Leadership in faculty recruitment and professional development and retention. Administration has been a critical partner with Senior Leaders to advance the mission and new strategic initiatives during the last five years through support of the transformational enterprise-wide executive leadership structure and new enterprise-wide administrator elevated to the executive leadership of MC with 13 direct reports, responsible and accountable for the MCCCC across three sites, to lead and manage the MCCCC. This includes oversight and alignment of institutional commitment, strategic planning and evaluation efforts, and cancer clinical, research, and education programs which has culminated in the new 2030 Bold. Forward MCCCC Strategic Plan. Administration has been instrumental in facilitating the bi-directional priority setting process with site-specific Community Advisory Boards (CAB) to ratify Catchment Areas (CA) and identify priority cancers and cancer risk factors for each CA; leveraged new data science and visualization tools through implementation of EVAL, Velos and iLab; and launched the new MCCCC website and implemented communication strategies.